The Chronic Rhinosinusitis (CRS) Problem and an AI Driven Personalized Medicine Solution

SUMMARY: Chronic rhinosinusitis (CRS) is a highly prevalent disease that inflicts a severe quality-of-life
(QOL) impairment, with local symptoms of nasal blockage, congestion, loss of smell, nasal drainage,
headache, and recurrent infections. CRS is also appreciated for its prominent role as a compounding factor in
other respiratory diseases such as allergic rhinitis, asthma/COPD, and cystic fibrosis. General health concerns
including fatigue, sleep dysfunction, anxiety/depression, excessive medication usage, frequent physician visits,
and productivity loss often accompany nasal symptoms and contribute to overall health detriment. As a result
of local symptom burden and overall health disturbance, CRS has been ranked among the most severe health
ailments, alongside congestive heart failure and end-stage renal disease.
Among existing therapeutic options for CRS, outcomes vary widely. The stepwise approach to CRS
management results in slow and measured escalation of care only after repeated attempts at various medical
therapies. As nuanced understanding of disease trajectories are uncovered through deep phenotyping of
individuals with CRS, a precision approach to this chronic disease is on the horizon. A patient’s decision to
commit to aggressive CRS treatment, such as surgery, includes many personal factors but inherently relies on
the likelihood for symptom improvement. Not surprisingly, the degree of symptom improvement gained is the
primary contributor to patient satisfaction with the intervention. Though numerous risk factors have been
associated with symptom severity and outcomes in CRS, there is a notable void in translation of these
observations to real-world, clinical decision-making. This is due to the many possible predictor variables,
unclear disease natural history, and weakness of traditional statistical approaches in dealing with noisy data.
Indeed, weighing these many considerations is a complex clinical task.
Our long-term goal is to create a personalized predictive model that can help individual patients understand
their likely outcomes with available therapeutic options. Translating research observations into a
comprehensible platform for shared decision-making, precision medicine, and rational allocation of system
resources (i.e., cost-benefit analyses) would be truly innovative in CRS. Our central hypothesis is that machine
learning and artificial intelligence approaches can be applied to myriad demographic and clinical data to infer
clinical outcomes for individuals deciding when to pursue surgical treatment for CRS. The proposed research is
significant because of its potential to: (1) illuminate how disease manifestations occur in some but not all CRS
patients, (2) predict patient trajectories and inform clinical interventions, (3) support real-time clinical decision
making, (4) develop new patient-centered treatment algorithms, and (5) serve as an initial study of predictive
analytics informing the decision for elective surgical therapies in chronic disease.

Public health relevance
PROJECT NARRATIVE Chronic rhinosinusitis is estimated to affect 10-12% of American adults and is one of the top ten most costly medical conditions in the United States. It is associated with severe but variable quality of life detriment, and this study’s focus on individualized treatment outcomes will help understand receptiveness to machine learning/artificial intelligence in clinical care, illuminate disease phenotypes, inform personalized clinical decision-making, and improve patient satisfaction. The proposed research is relevant to the part of the NIH’s mission to develop fundamental knowledge that will enhance health, reduce illness and disability, and enhance quality of life.